Incremental Hemodialysis for Veterans in the First Year of Dialysis (IncHVets): A Pragmatic, Multi-Center, Randomized Controlled Trial

PROJECT SUMMARY
Each year approximately 12,000 Veterans develop end-stage renal disease (ESRD) and initiate dialysis
treatment. These patients comprise >10% of the US incident ESRD population. Dialysis is costly and
associated with impaired health-related quality of life (HRQOL) and high mortality risk, particularly in the first
dialysis year. The current paradigm is to start treatment with full-dose thrice-weekly hemodialysis (HD)
irrespective of patients' residual kidney function (RKF), and this abrupt transition increases patients' and care-
partners' burden and suffering and may limit their preferences. Furthermore, recent evidence suggests that
Veterans who receive dialysis in a VA center have greater survival compared to those treated in non-VA units.
Although not currently the standard of care, evidence suggests that a gradual or incremental dialysis
transition using an initial twice-weekly HD schedule may confer substantial benefits including more dialysis-
free time, longer RKF preservation, vascular access longevity, less intradialytic hypotension and end-organ
damage, reduced post-dialysis fatigue, and less patient suffering. Hence, an incremental dialysis transition
may result in improved HRQOL through improved physical function, less fatigue, greater energy, and
improved patient satisfaction and life participation by mitigating the burden of excessive dialysis in daily life.
Pragmatic studies with immediate clinical impact are urgently needed to shift the focus of dialysis from an
abrupt thrice-weekly HD start to a safe and effective personalized dialysis regimen. Moreover, implementing a
twice-weekly HD schedule would allow 20% more Veterans to receive care within a VA-based dialysis unit.
In the spirit of RFA CX-21-006 for clinical trials, in this multiple-PI, multi-site, pragmatic, 1:1 randomized
controlled trial (RCT), parallel with Veterans' routine dialysis therapy, we will test the safety and efficacy of an
incremental twice-weekly HD protocol, compared to standard-of-care thrice-weekly HD, in Veterans who meet
predefined eligibility criteria. We plan to compare twice-weekly (incremental) with thrice-weekly (conventional)
HD initiation in 252 Veterans with incident ESRD, who will transition to maintenance HD therapy in six VA
centers. Using quarterly assessments for up to 12 months, we will examine the Short Form 36 (SF36) HRQOL
physical component score as the primary outcome, as well as Dialysis Symptom Index and SF36 energy/
fatigue score as secondary endpoints. Additional secondary outcomes will include preservation of RKF,
dialysis adequacy, nutritional status, and protein-energy wasting markers to be measured quarterly. Safety
assessments will include mortality, dialysis withdrawals, emergency room visits, hospitalizations,
hyperkalemia, and major adverse cardiovascular events. In a substudy examining exploratory outcomes in
112 Veterans from three VA centers in the parent trial, we will also examine of cardiac measures including left
ventricular mass, as well as nutritional/physical function indices of muscle mass and physical performance.
Our proposed pragmatic RCT addresses a major unmet need in Veterans with incident ESRD initiating
dialysis by focusing on improving HRQOL and preserving RKF, the two strongest predictors of survival and
patient satisfaction. The results of this study may enable more Veterans to receive therapy in a VA based
dialysis center. Our study may lead to a paradigm shift with immediate impact on kidney care in Veterans and
in the broader ESRD population. The pragmatic design will permit a rapid scaling-up of the interventions in
larger settings since the RCT takes advantage of resources and personnel that are readily available in VA
centers under experienced investigators and clinicians across multiple VA sites nationwide. This proposed
study challenges the current standard of care of outright thrice weekly HD in the first year of dialysis therapy,
during which patients' suffering and mortality are the highest, and is less likely to be supported by for-profit
dialysis providers given the perceived reduction in revenue if twice-weekly HD is to be implemented broadly.

Public health relevance
PROJECT NARRATIVE In this pragmatic clinical trial, which will dovetail with Veterans' routine outpatient dialysis clinic visits in six VA medical centers, we will study 252 Veterans with kidney disease who need to start dialysis treatment. If a Veteran is eligible for the study by making enough residual urine, he/she will have a 50% chance to be offered the usual three-times-per-week dialysis vs. twice-per-week dialysis that is gradually increased to three-times- per-week over one year. We will compare health-related quality of life, how long residual kidney function lasts, and other measures including safety in these two groups. By conducting this study, we hope to understand 1) whether starting dialysis with less frequency is safe, effective, and can help Veterans and their care-partners to better cope with dialysis, and 2) if incremental dialysis can result in major cost benefits to the VA health care system, thus allowing more patients to stay in VA dialysis clinics vs. being transferred to outside clinics.